ACQUISITION OF A QTRAP 7500 HYBRID QQQ/LIT MASS SPECTROMETER FOR PEDIATRIC TRANSLATIONAL RESEARCH

ABSTRACT
The ultrahigh-performance liquid chromatography-tandem mass spectrometry (UHPLC-MS/MS) system
consisting of a SCIEX QTRAP® 7500 MS System and Shimadzu Nexera Series 40 UHPLC system, contained
in this proposal, represents the most innovative LC/MS-based instrumental platform for small-molecule
quantitative bioanalysis on the market. At present, NIH-funded PIs working across a number of Texas Children’s
Hospital (TCH) Departments are increasing their application of quantitative mass spectrometry (MS)-based
bioanalysis in support of their translational research programs in pediatric medicine. These Departments include
Pediatrics-Gastroenterology, Hepatology, and Nutrition; Nephrology; Cardiology; Obstetrics and Gynecology;
and, Laboratory Medicine. Currently, the Texas Children’s Microbiome Center (TCMC) is the only TCH-based
facility, in the entire Texas Medical Center (TMC) campus that possesses UHPLC-MS/MS instrumentation and
expertise. The TCMC – Metabolomics and Proteomics Mass Spectrometry Laboratory (TCMC-MPMSL) has
witnessed steady growth in sample volume from 2020 to 2023, and our single UHPLC-MS/MS system is currently
analyzing ~9,000 samples per annum while consuming ~90% of the available instrument capacity. The reasons
for our funding request are two-fold: 1) expand our bioanalytical capacity to support the increasing levels of
pediatric-based translational research being performed at TCH; and, 2) upgrade our instrumental capabilities to
drive new biomedically-relevant discovery in support of pediatric patient care at TCH. Altogether, the instrument
included in this proposal will provide much needed capacity and new capabilities that the TCMC-MPMSL can
leverage to advance the basic and clinical research efforts of NIH-funded investigators at TCH in pediatric
medicine.

Public health relevance
Project Narrative The proposed UHPLC-MS/MS instrumentation will provide our lab with much needed bioanalytical capacity and capability to aid in our quest to discover the molecular underpinnings of human disease in the pediatric patient. Our lab supports basic and clinical researchers working in the fields of microbiology, microbiome, and infectious disease, childhood obesity, inflammatory disorders (MIS-C in COVID-19 Infection) and gastroenterology and hepatology disorders – the basic and clinical research that we support has a direct impact on the lives of the patients that we serve.